Project 5

Project 5 ABSTRACT
The effects from hazardous substances in the environment can be compounded by their mobilization and
redistribution in polluted sediment, soil, water and air following natural disasters and emergencies. Of immediate
concern is the safety of safe water and food supplies. Other threats include soil contamination (lawns, community
gardens, parks and recreational areas), along with increased risk of human dermal and inhalation exposures
near the site of the impact. A major challenge associated with these emergencies is protecting vulnerable
communities and neighborhoods, first responders to the disaster, frontline personnel, and those involved in the
management and cleanup of the site. Thus, the ability to rapidly minimize hazardous substance effects during
disaster events is a critical need. In Aim 1 of this proposal, multicomponent sorbents will be synthesized from
diverse materials and compounds that are generally recognized as safe (GRAS), and these sorbents will tightly
bind environmental chemicals and design mixtures with high capacity and affinity. The reaction kinetics,
thermodynamics and fundamental mechanism(s) involved in interactions between the surfaces of selected
sorbent materials and hazardous environmental chemicals and mixtures will be determined using currently
available in vitro methods. Computational methods will be used to validate and provide fundamental insights, as
well as to predict sorbent properties and screen for optimum GRAS amendments, thus providing feedback and
integration with all experiments. Well-established animal and plant organisms that possess a low tolerance for
environmental chemicals in water, soil, and sediment will include the Cnidarian model system (Hydra vulgaris),
the Lemna minor (duckweed) assay, and the Caenorhabditis elegans nematode assay. These living (in vivo)
model systems will be used to predict the toxicity of polluted samples and to validate the efficacy of our selected
sorbents and our in vitro and in silico results. In Aim 2, multicomponent sorbents will be developed that will
remove hazardous substances from contaminated food, drinking water and soil. Novel barrier formulations will
be developed for skin protection and for filter inserts in protective masks to reduce dermal and inhalation
exposures to chemicals. In Aim 3, our in vivo models will be used to evaluate real-life environmental samples
from disaster sites and well-characterized superfund sites. In these studies, optimal sorbents and levels of
inclusion that will result in detoxification of hazardous substances will be determined. Existing collaborations with
Community Engagement Core, well-established technology transfer expertise, and interdisciplinary interactions
in Project 5 will add an important capability and dimension to the overall Center. The project-to-field pathway for
the development of broad-acting sorbents and formulations for hazardous chemicals during the course of our
study has been firmly established. We have identified relevant stakeholders and vulnerable communities that
will benefit from these products. It is expected that sorbent and barrier technology developed in this research will
result in reduced chemical exposures in people and animals during disasters and emergencies.

Public health relevance
Project 5 NARRATIVE This project is developing broad-activing sorbent materials that can be used to minimize exposures to hazardous chamicals during and after environmental and man-made disasters. The outcomes of this project will be of direct use by first responders, frontline personnel, vulnerable community members, and others exposed to hazardous chemical substances during disasters and emergencies. Ultimately, the strategy of using multicomponent sorbents and novel barrier formulations will effectively decrease chemical exposures through ingestion, dermal contact and inhalation.